Crosstalk between brassinosteroid and autophagy pathways in the regulation of plant growth and stress responses

Project Summary
The long-term goal of this project is to determine how growth, development and stress responses are
coordinated in Arabidopsis, a model plant with extensive genetic, genomic and proteomic resources. This will
be accomplished through detailed mechanistic studies that will provide insights into the fundamental conserved
biological processes of steroid hormone signaling and autophagy. Brassinosteroids (BRs) are plant steroid
hormones that promote growth and development and regulate stress responses. Autophagy occurs in all
eukaryotes and degrades organelles and proteins, especially under stress conditions. We have identified
multiple mechanisms by which BR signaling and autophagy are coordinated, and generated a regulatory
network by combining multiple types of ‘omics data. Key points of interaction between the pathways include
degradation of BES1, a transcription factor mediating BR responses, by selective autophagy to reduce growth;
and phosphorylation of the TORC subunit RAPTOR1B by the BR-regulated GSK3-like kinase BIN2, leading to
an increase in autophagy in response to stress via a switch in TORC substrate specificity. Our new data
indicate that the MAP kinase MPK6 functions downstream of BIN2 to negatively regulate autophagy, BIN2
phosphorylates ATG13 to directly regulate autophagy, and BES1 transcriptionally regulates autophagy gene
expression through histone 3 lysine 27 (H3K27) methylation, by recruiting H3K27 demethylase REF6 and
methyltransferase CLF. We hypothesize that BR signaling regulates autophagy to coordinate plant growth and
stress responses, through multiple mechanisms including BIN2 regulation of MAPK6, TORC and ATG13 and
BES1 regulation of ATG gene expression. We propose the following Specific Aims to test the hypotheses: 1) to
establish the mechanisms of BIN2 and MPK6 regulation of TORC in the control of autophagy and growth; 2) to
investigate how BIN2 and TOR phosphorylation of ATG13 regulates its function by mapping phosphorylation
sites and mutational analyses; 3) to establish the mechanisms and network through which BES1, together with
histone H3K27 demethylase REF6 and methyltransferase CLF, regulates the expression of ATG12 and other
genes to control autophagy. These studies will leverage the genetic and genomic resources in Arabidopsis and
use multi-omics technologies to generate and integrate information ranging from transcriptome changes to
phosphorylation sites and protein-protein interactions. These innovative approaches have the potential to
provide transformative knowledge on the mechanisms of integration of growth and stress responses across
eukaryotes. For example, autophagy is involved in many human diseases including neurodegenerative
diseases, such as Alzheimer, Parkinson and Huntington, and links with steroid hormone action are now being
identified, although mechanisms remain obscure. Autophagy also plays critical roles in cancer development,
and drugs that modulate autophagy and/or TORC signaling are in clinical use or under development. The
proposed studies can therefore provide important insight into processes related to human health.

Public health relevance
Project Narrative Autophagy is critical for stress responses and pathogen defense in many organisms and is involved in human diseases, including neurodegenerative diseases such as Alzheimer, Parkinson and Huntington diseases. Links with steroid hormone action are now being identified, although mechanisms remain obscure. Autophagy also plays critical roles in cancer development, and drugs that modulate autophagy and/or TORC signaling are in clinical use or under development. Since many of the proposed regulators to be investigated (GSK3 kinase, MPK6 kinase, TOR/Raptor, ATG1/ATG13 as well as H3K27 methyltransferase and demethylase) are conserved between plants and animals, the proposed studies will provide a unique and effective approach to address an important biological question on how organisms coordinate growth and stress response. The proposed studies can therefore provide important insight into processes related to human health.